Clinical Evaluation of Chlorotoxin-redirected Chimeric Antigen Receptor (CAR) T cells for Treatment of Glioblastoma

PROJECT SUMMARY
Despite increasingly aggressive standard of care treatments, patients with glioblastoma (GBM) have a poor
prognosis that has remained unchanged for decades, and this represents a fundamental unmet medical need.
Progress in immunotherapy across a broad range of tumor types provides hope that immunological approaches,
including CAR T cell therapy, may improve outcomes for patients with GBM. This is supported by the ability of
CD19-targeted CAR T cells to eliminate B cell malignancies in the central nervous system (CNS), as well as
early clinical experiences showing safety and disease-modifying activity of CAR T cells in GBM. One major
challenge for GBM immunotherapies is the phenotypic heterogeneity of GBM tumors coupled with the scarcity
of targetable tumor-associated antigens. As an approach to address this challenge we have developed a novel
CAR that exploits the selective and broad GBM-binding properties of chlorotoxin (CLTX). CLTX is a 36-amino
acid peptide component of scorpion venom that binds specifically to GBM and other tumors with minimal cross-
reactivity to non-malignant cells. Previous early phase clinical trials have established safety of CLTX when used
as a GBM-targeting peptide for imaging and radiotherapy. Our preclinical studies demonstrate that CLTX-CAR
T cells mediate potent antitumor activity in vitro and in vivo, with no observable effector activity against normal
human cells or when adoptively transferred into cross-reactive mouse models. We now aim, in this proposal, to
clinically test the hypothesis that CLTX-CAR T cells will be safe and mediate antitumor effects when
locoregionally delivered to the CNS in patients with GBM. Aim 1 will evaluate the feasibility, safety and response
rates of CLTX-CAR T cells in patients with recurrent GBM in a phase 1 clinical trial. CLTX-CAR T cells will be
delivered locoregionally via intratumoral [ICT] and intracerebroventricular [ICV] catheters. Aim 2 will assess
CAR-mediated immunological changes associated with response and resistance. Taking advantage of our
catheter-based locoregional delivery strategy that allows sampling of the CSF throughout treatment, we will
monitor surrogate markers of CAR T cell activity, including CAR T cell persistence and changes in inflammatory
cytokines and endogenous immune subsets. We will also compare the intrinsic characteristics across different
autologous CAR T cell products with clinical response. Aim 3 will investigate pathways of GBM tumor resistance
and CAR-induced tumor evolution pre- and post-therapy, investigating antigen escape pathways and adaptive
immunosuppressive mechanisms to CAR T treatment. The innovative use of scorpion-derived CLTX for tumor
targeting would be the first example of a natural peptide−based CAR in the clinic, potentially expanding CAR
designs beyond antibody- and ligand-based targeting domains. CLTX-CAR T cell targeting of a wide range of
GBM cells within individual tumors is significant in that it will expand our armamentarium and potentially help to
limit antigen escape and enhance tumor eradication, thereby improving outcomes for patients with GBM.

Public health relevance
NARRATIVE The proposed research seeks to expand the scope of chimeric antigen receptor (CAR) T cell therapy against glioblastoma (GBM) by using the tumor-specific targeting capabilities inherent in chlorotoxin (CLTX) to redirect T cells against GBM. CLTX-CAR T cells are expected to broadly target heterogeneous GBM populations and be safe and well tolerated, with negligible activity against normal tissues. The proposed clinical trial aims to improve our understanding of tumor response to therapeutic pressure and key drivers of response and resistance to CAR T cell therapy, with the goal of improving outcomes of patients with GBM.